Optimizing treatment response in VA Specialized Intensive/Inpatient PTSD programs

Background: Posttraumatic Stress Disorder (PTSD) affects approximately 23% of returning Veterans and produces significant psychological, physical, and economic burdens. Although most Veterans with PTSD are treated on an outpatient basis, the VA has 39 Specialized Intensive/Inpatient PTSD programs (SIPPs) designed to treat high-needs Veterans who require more intensive and closely monitored care. The treatment of patients enrolled in SIPPs is extremely costly; only 1% of VA patients with a PTSD diagnosis enroll in SIPPs but they account for 33% of VA's budget for specialized PTSD care. Furthermore, despite these costs, many patients undergoing treatment in SIPPs may experience only modest improvements in PTSD symptoms. Thus, the Institute of Medicine has recently called for strategies to improve treatment outcomes of VA PTSD treatment in general and residential programs specifically, making it clear the VA needs to carefully assess and address poor treatment response among Veterans receiving residential and other PTSD treatment. Objectives: The goal of this CDA is to optimize PTSD care by identifying individual- and program-level factors associated with poor treatment response in residential programs, which will greatly enhance the VA's ability to target and improve treatment approaches for these high-need, high-cost individuals. Aim 1 will identify individual- and program-level predictors of treatment response in residential programs nationwide. Aim 2 will further elucidate factors associated with poor PTSD treatment response, using a qualitative approach with patient, provider, and administrator interviews at a VISN 10 program and nationally at 3 high-performing and 3 low-performing programs (based on average symptom change and percent of patients readmitted within 14 days of discharge). Aim 3 will pilot an adaptation of an existing treatment or health services intervention based on findings from the initial study aims, data on treatment practices at high-performing sites, and assessment of feasibility from an expert panel consisting of the mentorship team, operational partners, and frontline staff. Methods: This research will be guided by the theory of Resources, Life Events and Changes in Psychological States. Aim 1 will assess predictors of poor response using multilevel modeling of nationwide clinical information collected by the Northeast Program Evaluation Center. Variables of interest will include individual- level resources and factors such as comorbidities, social contextual resources (e.g. low social support), and program resources such the availability of evidence-based treatments. Aim 2 will utilize qualitative analytic methods to assess individual and program-level predictors of response by interviewing patients and providers. Aim 3 will consist of a feasibility pilot conducted with 60 patients at a VISN 10 residential program for PTSD. Candidate: The PI's long-term goal is to become an independent VA health services investigator who develops and evaluates programs to improve outcomes for individuals with severe and difficult-to-treat PTSD and improve care quality for PTSD. During this CDA, the PI will build the foundation of a research program focusing on poor PTSD treatment response while building expertise in health services methods. The PI will complete training activities in: (1) multilevel modeling, program evaluation, and other health services methods, (2) qualitative and mixed methods, and (3) Implementation Science and cost analysis. The proposed research and training activities will provide the PI with the skills to inform improved PTSD care for Veterans. Environment: The PI will benefit from the wealth of resources supporting training and research that are available through the VA HSR&D Center of Innovation, the University of Michigan Department of Psychiatry, the Institute for Healthcare Policy and Innovation, and the School of Public Health. She will make full use of these opportunities and the supportive and coordinated mentorship team to enrich her current and proposed research. The proposed CDA research is highly significant and addresses key VA and ORD priority areas including mental health services research and advancing Point of Care Research in PTSD.

Public health relevance
Posttraumatic stress disorder (PTSD) is a debilitating disease characterized by re-experiencing, avoidance, negative alterations in mood and cognition, and hyperarousal. PTSD is a large and ever-increasing problem for our nation's Veterans. Though evidence-based PTSD treatment is generally effective, up to a third or more of individuals with PTSD respond poorly to treatment. Many poor responders are treated in residential VA PTSD programs. The current proposal will address the needs of poor responders in residential care by identifying individual- and site-level factors associated with good and poor PTSD treatment response, then piloting a tailored approach for poor response. Improving care for those at risk of poor response will improve efficiency of residential care, reduce the cost of care, and improve health outcomes for these individuals.